Odorant Receptor Expression and Sensitivity to Odorants

DESCRIPTION (provided by applicant): The application proposes to allow an investigator experienced in the molecular biology of the olfactory epithelium to cross the gap from his expertise in microarray-based genomics to more computationally challenging next generation sequencing approaches. The plan includes: (1) training in R programming to allow the investigator take advantage of flexible analysis methods for ChIP-seq and RNA-seq techniques, (2) mentored pilot experiments in both of these approaches, and (3) mentored analyses of the data. The pilot studies take advantage of a unique resource that allows purification of olfactory neurons expressing subsets of odorant receptors to work toward testing two fundamental hypotheses about odorant receptors. (1) Active chromatin modifications (which can only be detected by enrichment for neurons expressing an odorant receptor) are critical for the tightly regulated expression of odorant receptors. Active chromatin modifications will be measured by ChIP-seq. The exquisitely specific control of odorant receptor expression is perhaps the greatest remaining mystery about the function of olfactory sensory neurons. (2) Odorants activate sets of odorant receptors that may overlap but must have at least one distinct member if the odorants can be discriminated. Enrichment for olfactory sensory neurons marked by expression of GFP from an activity-dependent gene locus will allow RNA-seq methods to identify sets of odorant receptors activated by specific odorants. Understanding the fundamental question of how hundreds of odorant receptors allow the detection and discrimination of thousands of odorant chemicals should help explain some causes of hyposmia and anosmia; and should allow the future development of odorant agonists and antagonists that could be used to improve the quality of human life.

Public health relevance
PUBLIC HEALTH RELEVANCE: Unlike color vision and pitch detection by the ear, how the quality dimension of odorant stimuli (differences in chemical structure) is divided among the detectors (odorant receptors) remains a mystery. Differences in the pattern of receptors activated must exist between odorants that can be discriminated, but these patterns are unknown. Given the strict expression of just one odorant receptor in each olfactory sensory neuron, these patterns depend critically on mechanisms controlling expression of the odorant receptor genes, mechanisms that remain mysterious and when defective, may also contribute to hyposmias and anosmias.